RADIOGRAPHIC EVALUATION OF OSTEONECROSIS

This is an international referral center for patients with osteonecrosis. Information gathered on all patients including (but not limited to): radiographic assessment, previous steroid treatment, and treatment are entered into our database. Approximately 60 patients are entered each year. Our long-term goal is to gain a better understanding of the etiologies and pathogenesis of this disease. The short-term goal is to evaluate the current clinical assessments and treatments of our patient population.